Identification of luteolin as a BRAF-degrading molecule for developing new therapeutic agents

There are still unmet clinic needs for more effective and long-lasting targeted therapy against BRAF in
advanced melanoma skin cancer and other BRAF-mutated cancers. This exploratory project aims to further
understand molecular regulation of BRAF and to develop such new therapy drugs that are mechanistically
different than the current clinic drugs. The long-term goal is to develop luteolin analogues as a new class of
therapeutic agents on MAPK-dependent cancers. The short-term goal of this project is to understand how
luteolin induces BRAF degradation. Luteolin inhibited melanoma cell growth in vitro and in vivo, and exhibited
substantial synergistic effect with Vemurafenib in all melanoma cell lines examined. Luteolin inhibited BRAF
kinase activity in a cell-free system, and induced BRAF degradation in melanoma cells, which led to down-
regulation of the MAPK pathway. Luteolin was docked to Cys532 in BRAF crystal structure by a computational
docking analysis. It is thus hypothesized that luteolin inhibits melanoma tumor growth primarily via direct binding
to BRAF protein at the druggable Cys532 residue, resulting in proteasome-mediated BRAF degradation. BRAF-wt
and BRAF-mt may use different mechanisms. Two specific aims are proposed: Specific Aim 1: To identify the
role of Cys532 in BRAF stability and kinase activity. The role of Cys532 in BRAF function is largely
unknown but was computationally predicted as “druggable”. In this aim Cys532 will be genome-edited to
become a glycine (C532G) or a Tyr (C532Y) in BRAFwt/wt and BRAFV600E/V600E backgrounds. BRAF protein
stability and kinase activity will be analyzed by western blots in the various edited genetic backgrounds.
Whether luteolin-induced ROS play a role in BRAF stability and activity through oxidation of Cys532.
Additionally, drug sensitivity (luteolin, Vemurafenib or combination of luteolin/Vemurafenib) will be assayed and
compared in these genetic backgrounds in vitro and in vivo. Drug Affinity Responsive Target Stability (DARTS)
assay will be used to evaluate direct binding of luteolin to BRAF with various mutations. Specific Aim 2: To
identify the mechanism of luteolin-induced BRAF degradation. Luteolin-induced BRAF degradation is
proteasome-dependent but a specific E3 ligase is not identified. Anaphase-Promoting Complex (APC) and the
SKP1/CUL1/F-Box complexes (as well as USP28 which counteracts SKP activity) were reported to be involved
in BRAF protein degradation. In this aim small molecule inhibitors specific for APC or for SCF will be used to
determine luteolin-mediated E3 ligase for BRAF destruction. Lentiviral shRNA approach will be used at last to
validate the specific E3 ligase complex by knocking down the core component of the ligases (APC10 or SKP1).
In parallel, we identified USP35 and six additional E3 ligases through RNA-Seq as potential luteolin targeted
enzymes which will be examined for their impact on BRAF degradation. Completion of these aims will enable
us to initiate a drug discovery route which is translatable into clinical trials, either for new drugs, or to expand
BRAFi/MEKi treatment to perhaps BRAF-wild type patients, or even other cancer types.

Public health relevance
We have demonstrated that a natural compound luteolin induced protein degradation of BRAF oncogene, leading to in vitro and in vivo melanoma growth inhibition as single agent and as a combination with the clinic drug Vemurafenib. This presents an excellent opportunity to develop novel BRAF inhibitors and novel combination therapy methods for melanoma, which are still urgently needed as current targeted therapy methods often show therapy-induced drug resistance. This project is expected to dissect the mechanism of action by which luteolin induces protein degradation of BRAF, which is an important step towards developing luteolin-based analogues for new therapy methods.